Neuro-Immune Interaction in Cancer Development

While the presence of nerves in solid tumors has been observed for hundreds of years, investigation of the
impact of these nerves on tumor growth has only been initiated in the last 10 years. The bulk of this work has
focused on the impact of neurotransmitters on tumor cell growth and metastasis, however immune cells also
express receptors for a wide variety of neurotransmitters, which can have immune-activating and immuneinhibiting
properties. In preliminary studies using a murine breast cancer model, we have found that the
presence of sensory nerves is necessary for tumor inhibition by the adaptive immune system. Furthermore,
blockade of a specific neurotransmitter produced by sensory nerves, calcitonin gene related peptide (CGRP)
inhibited tumor growth and improved T cell infiltration into tumors, suggesting both pro- and anti-tumor
activities for sensory nerves in breast cancer. In this project, we will decipher how sensory nerves promote
adaptive immune responses to tumors. We will also investigate the mechanism by which CGRP inhibition
improves tumor control, and whether this treatment can synergize with anti-PD-1 immunotherapy. Finally, we
will evaluate whether presence of sensory nerves, adrenergic nerves, or specific neurotransmitters including
CGRP correlate with immune infiltration and response to chemotherapy in breast cancer patients. Overall
these studies will provide critical information on a potentially novel immunotherapeutic pathway that can be
modulated in patients to promote tumor control.

Public health relevance
Breast cancer is the second leading cause of cancer death in women, and there is a critical need to identify new targets to treat this cancer. We have found that sensory nerves inhibit breast cancer growth in mice by acting on the immune system. In this proposal we will determine whether manipulation of nerve signaling in tumors can be used to treat cancer and promote anti-tumor immune responses.